Comprehensive monitoring of diverse cancer outcomes using genomic and epigenomic sequencing of cfDNA

PROJECT SUMMARY
Cancer monitoring is essential for the early detection and timely intervention of various adverse outcomes, such
as minimal residual disease (MRD), recurrence, and side effects. Plasma cell-free DNA (cfDNA) has shown
great promise for cancer monitoring due to its unique advantages: (1) noninvasiveness, which enables repeated
collection; (2) comprehensiveness, as cfDNA contains DNA from different tumor clones; and (3) capability to
inform side effects, as cfDNA comes from various organs, and damage to a specific organ can lead to increased
DNA release from that organ. These advantages make cfDNA ideal to monitor various adverse outcomes. Yet
a gap exists between the potential of cfDNA applications and method development. Current usage of cfDNA is
limited to MRD/recurrence detection with small mutation panels. The proposed project aims to develop a
computational system, TreatMonitor, for ultrasensitive, comprehensive, broadly applicable, and affordable
cancer monitoring using multi-omics profiling of cfDNA. Dr. Li will improve MRD/recurrence monitoring by
integrating exome- and methylome-wide tumor signals (Aim 1, K99). She aims to enable sensitive monitoring of
side effects by accurately and comprehensively quantifying tissue contribution in cfDNA using deep learning
(Aim 2a, K99), and identifying tissue damage from abnormally altered tissue contributions in patients’ cfDNA
samples (Aim 2b, R00). Throughout the K99 and R00 phases, the method will be validated technically and
clinically. TreatMonitor will be the first to achieve several milestones: the first approach to integrate cfDNA
exome and methylome for monitoring, and the first cfDNA-based method for monitoring side effects during
cancer treatment. TreatMonitor thus offers a comprehensive solution to monitor various adverse outcomes,
informing early intervention, facilitating cfDNA-based cancer research, and ultimately improving the quality of
life of cancer patients. Dr. Li’s’ long-term goals are to understand genetic and epigenetic influences on cancer
treatment outcomes and to develop prognostic and predictive models that guide treatment selection.
The overall training objective is to provide Dr. Li with additional years of mentorship to become a highly qualified
independent investigator at the intersection of precision oncology, computational biology, and statistics. Training
goals include the development of competencies in (1) the clinical and biological characteristics of cancer and its
treatment, (2) advanced statistical methods in deep learning and longitudinal data analysis, and (3) professional
development skills. Through this training, her background in statistics, computational biology, and liquid biopsy
will be integrated to solidify her expertise in precision oncology as she transitions to an independent tenure-track
faculty position. During the K99 phase, Dr. Li will be under the primary mentorship of Dr. Steven Dubinett, with
a strong co-mentoring team (Drs. Wing Hung Wong and Samuel French). UCLA has a vibrant interdisciplinary
community for cancer research with active collaboration, and all of the required equipment and facilities.

Public health relevance
PROJECT NARRATIVE Many cancer patients experience adverse outcomes such as recurrence and side effects, but no effective and comprehensive monitoring method has been developed for early detection and timely intervention. This proposal aims to develop a computational system, TreatMonitor, for ultrasensitive, comprehensive, broadly applicable, and affordable cancer treatment monitoring using integrative multi-omics analysis of cell-free DNA, for the first time enabling comprehensive detection of various adverse outcomes, e.g., minimal residual disease, recurrence, and side effects. We anticipate that this system will significantly aid the early detection of and intervention of various adverse outcomes, facilitate cell-free DNA-based clinical and methodological research, and ultimately improve the quality of life of cancer patients.